Spatiotemporal Modeling of MRI Brain Lesion Trajectories of Biomarker Discovery

? DESCRIPTION (provided by applicant): We propose to develop statistical methods for the analysis of longitudinal magnetic reso- nance imaging (MRI) data for patients with multiple sclerosis (MS). Disease biomarkers identiﬁed from MRI are necessary for studying disease progression in observational studies and for assessing treatment effects of therapies in clinical trials. We propose statistical methods for the analysis of longitudinal MRI intensity time courses that integrate information across multiple modalities. The proposed methods will harness the complex data structure of clinical MRI for identifying biomarkers that can be utilized in future studies and that are implementable in MS centers across the country.

Public health relevance
PUBLIC HEALTH RELEVANCE: Identiﬁcation of magnetic resonance imaging biomarkers for patients with multiple sclerosis (MS) that describe brain changes over time is crucial for observational studies of MS and treatment clinical trials. We propose to develop rigorous statistical methods for analyzing high-dimensional longitudinal imaging data before, during, and after the formation of white matter lesions in patients with MS.